ULTRA-HIGH FIELD MICROSCOPIC MAGNETIC RESONANCE IMAGING OF ALZHEIMER’S PATHOLOGY

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. Primary support for the subproject and the subproject's principal investigator may have been provided by other sources, including other NIH sources. The Total Cost listed for the subproject likely represents the estimated amount of Center infrastructure utilized by the subproject, not direct funding provided by the NCRR grant to the subproject or subproject staff. The impact of Alzheimer's disease (AD) on the aging population of the world is growing. While there is an extensive literature on the importance and pathological evolution of amyloid plaques in AD, imaging this pathogenesis remains elusive.